AmbassADDOrs for Health: Maintaining youth-friendly HIV prevention services to young women through drug vendors

SUMMARY
Adolescent girls and young women (AGYW; ages 15-24) in sub-Saharan Africa face the dual threats of HIV
infection and unintended pregnancy that severely undermine their long-term wellbeing. However, despite the
urgent need to reach AGYW with sexual and reproductive health (SRH) services, health systems are often ill
equipped to overcome the numerous barriers to health care services faced by AGYW. We have successfully
piloted and are now in the process of evaluating the effectiveness (in an ongoing cluster randomized controlled
trial) of Malkia Klabu (MK), a loyalty program intervention that creates AGYW-friendly drug shops where
AGYW can access HIV prevention services and contraception. The motivation for this approach is the growing
recognition that drug shops, which are widely distributed and vastly outnumber health facilities, can promote
beneficial health behaviors, bridge gaps in health services, and mitigate health workforce shortages. Though
HIV testing is the gateway to HIV prevention and care, and self-testing with oral fluid holds promise for
overcoming many of these obstacles, neither are widely accessible to AGYW. The goal of this proposed study
is to build on the success of MK and move towards sustainability and scale-up, identify the critical supply-side
features drug shops need to help independently sustain the MK demand-generating AGYW intervention,
including HIVST kit distribution, following a fully subsidized research period.
We therefore propose to extend our implementation-effectiveness trial study period and additionally test
program adoption, implementation, and maintenance. To do so, we will emulate real-world market
conditions by implementing shop-initiated HIVST procurement, phasing out HIVST kit subsidies (from 100% to
0), and testing continuation of 2 financing models for MK product reimbursements—fully reimbursable
(government-supported scenario) vs none (fully privately supported scenario). After co-designing prosocial
motivational pitches with our Pharmacy Advisory Board, we will test adoption and continuation of MK in control
and intervention shops currently enrolled in our ongoing effectiveness trial, respectively, for 3 months (Aim 1),
and maintenance by gradually phasing out subsidies of shop-initiated HIVST kit procurement over the next 36
months; without HIVST kit subsidies in the last phase, continuation will be tested by comparing fully
reimbursed vs. fully shop-financed MK product distribution (Aim 2); mixed methods data will assess
implementation, fidelity, receptivity, behavior change pathways, and motivational contexts for understanding
shopkeeper engagement (Aim 3). At the end of the study, we will be well-positioned to inform our MOH and
Pharmacy Council partners how best to scale MK under different HIVST kit subsidy levels and MK product
reimbursement models. Importantly, our study will contribute to generalizable learning about the structures
required for commercially sustainable public-private partnerships for high-impact public health interventions.

Public health relevance
NARRATIVE New and innovative strategies are urgently needed to increase the uptake of HIV prevention and sexual and reproductive health services among adolescent girls and young women (AGYW) in sub-Saharan Africa. To ensure the real-world sustainability of our demand-generating intervention for AGYW delivered by private drug shops, we will rigorously test supply-side subsidy structures for shopkeepers’ provision of HIV-self testing kits and contraceptives to AGYW combined with prosocial motivational supports. Our combination of non-monetary and monetary support structures aims to emulate real-world health financing models for public-private partnerships and ultimately aims to improve equity in access to critical prevention services for AGYW at scale.